CE24-013 - Community-based evaluation of a novel, system-wide harm reduction strategic plan for people experiencing homelessness in New York City

PROJECT SUMMARY/ABSTRACT
Overdose (OD) and homelessness are two interlinked national crises in the United States (US). More than 1.25
million people experience homelessness each year, and drug OD is the leading cause of death among people
experiencing homelessness (PEH). OD rates among PEH are 30–40 times higher than the general population.
However, OD prevention interventions tailored for PEH remain underdeveloped, with limited evidence on
effective strategies that reach this high-risk population. To fill this gap, this study will evaluate the
implementation and impact of the New York City (NYC) Department of Homeless Services’ (DHS) Harm
Reduction Strategic Plan (HRSP), a broad suite of shelter-based interventions tailored to PEH with the goal of
reducing client OD risk. The HRSP—which combines universal harm reduction education provided to all clients
at shelter entry (approximately 45,000 people annually) with an array of focused harm reduction and treatment
services—is the first intervention of its kind implemented at scale in a large homeless services system in the
US. We propose a rigorous, mixed-methods design that integrates epidemiological, data science, and
qualitative methods to holistically evaluate the HRSP in collaboration with NYC DHS. Aim 1a is to estimate the
impact of the HRSP shelter-based interventions on OD risk using epidemiological methods for impact
evaluation applied to linked homeless services data, Medicaid claims data, and vital records. Aim 1b is to
identify multidimensional subgroup heterogeneity (e.g., by race/ethnicity and other sociodemographic
characteristics) in the impact of the HRSP interventions using a novel machine learning approach. Aim 2 is to
identify optimal combinations of HRSP interventions to reduce OD risk using a two-stage machine learning
strategy that will tease apart the impacts of simultaneously implemented HRSP component interventions. Aim
3 is to assess barriers and facilitators to implementation of the system-wide HRSP, and explore client and staff
perspectives on substance use-related impacts using in-depth interviews and focus groups with DHS clients,
staff, and key stakeholders. This innovative, community-partnered research is directly responsive to the CDC’s
Overdose Prevention Research Priority of evaluating innovative OD prevention strategies tailored for
populations facing a disproportionate burden of OD. This research is directly responsive to the current NOFO
through its focus on a new and untested model of OD prevention delivered to a high-risk group in a community-
based setting. In sum, we have a unique opportunity to rigorously evaluate the large-scale introduction of
place-based OD prevention interventions tailored for PEH, a population that experiences a disproportionate
burden of OD. The multidisciplinary investigator team will work with a Community Advisory Board to maximize
the impact of the research, which has been designed to provide actionable evidence to inform local and
national public health program and policy interventions.

Public health relevance
PROJECT NARRATIVE As overdose among people experiencing homelessness surges, it is critically important to identify effective strategies to stem the tide of overdose deaths for this highly marginalized population. The proposed community-partnered study will use advanced epidemiological and data science methods together with qualitative interviews to rigorously examine the implementation and effectiveness of a novel, systemwide Harm Reduction Strategic Plan suite of interventions administered across homeless shelters in New York City. The study will produce new practice- and policy-relevant evidence to inform local and national programmatic and policy interventions, laying the groundwork for widespread implementation of place-based overdose prevention strategies to meet the unique needs of individuals experiencing homelessness, a population at disproportionate risk of overdose death.